Genomic and Epigenomic Mechanisms of Maternal E-Cigarette induced Abnormal Brain Development

PROJECT SUMMARY/ABSTRACT
Maternal smoking is a well-recognized public health concern associated with increased neurodevelopmental
disorders and other health risks in offspring. Substantial evidence indicates various adverse effects of maternal
smoking or prenatal nicotine exposure on neonatal brain development, e.g., hyperactivity, reduced cognitive
performance, increased anxiety and depression, and increased susceptibility to brain injury. Electronic cigarettes
(e-cig) have become popular in pregnant women and young adolescents. Growing evidence suggests that
maternal e-cig use affects brain development, resulting in abnormal cortical neuronal morphology and aberrant
neuro-behaviors in offspring. Using a rat prenatal e-cig exposure model and single-nucleus sequencing, we
recently found that prenatal e-cig exposure disrupted excitatory-inhibitory (E/I) balance, ratio of excitatory/
inhibitory neurons, in the neonatal brain. E/I balance is crucial for normal brain development and functions, and
its disruption has been postulated to underlie the pathogenesis of many neurodevelopmental disorders, including
autism spectrum disorders, ADHD, and other psychiatric disorders. However, the underlying genomic and
epigenomic mechanisms are still not known. This investigation seeks to fill this knowledge gap. Our hypothesis
is that prenatal e-cig exposure induces epigenomic reprogramming and genomic alterations in the developing
brain, which cause an E/I imbalance and consequently an increased risk for neurodevelopmental disorders.
Exploiting the prenatal e-cig exposure model we developed recently, we propose three specific aims. Aim 1 will
determine the spatial-temporal effects of prenatal e-cig exposure on brain development and progression of E/I
imbalance using spatial genomics and single-cell sequencing techniques. Aim 2 will determine the epigenomic
mechanisms regulating the prenatal e-cig induced E/I imbalance. Aim 3 will investigate whether prenatal e-cig
causes genomic alterations (i.e., SNVs and CNVs) that are involved in E/I imbalance. Many cutting-edge
genomic and epigenomic technologies are exploited in our studies, including spatial genomics, single-nucleus
RNA-seq and chromatin accessibility (snATAC-seq), and state-of-the-art bioinformatics tools. OUTCOMES: Our
study will: 1) identify the brain regions that show the E/I imbalance caused by prenatal e-cig exposure; 2) identify
the key genes, genomic changes and epigenomic regulations responsible for the prenatal e-cig induced E/I
imbalance; 3) produce a large amount of unprecedented omics data on the rat brain prenatally exposed to e-cig.
IMPACT: Using a well-established intrauterine e-cig exposure model coupled with cutting-edge genomics and
epigenomics approaches, our proposed studies will elucidate the genomic and epigenomic mechanisms
underlying maternal e-cig induced abnormal brain development, providing valuable new insights into the effects
of e-cig on the early central nervous system development, which will help explore promising molecular and
cellular therapeutic targets for treating e-cig vaping-induced brain damage.

Public health relevance
NARRATIVE Using a unique rat intrauterine e-cigarette exposure model coupled with cutting-edge genomic and epigenomic approaches including the spatial genomics and single-cell sequencing technologies, this project will determine the genomic and epigenomic mechanisms underlying prenatal e-cigarette caused abnormal brain development in the offspring. A large amount of genomic and epigenomic data will be produced, including whole genome sequencing, DNA methylomes, ATAC-seq chromatin accessibility, RNA-seq transcriptomes, and single-nucleus RNA-seq/ATAC-seq, which will provide valuable new insights into the effects of e-cigarette on early central nervous system development, and help explore promising molecular and cellular therapeutic targets for treating e-cigarette vaping-induced brain damage.